Symposium on imaging and modulation of neural activity in vivo: From the Eye to the Brain

Project Summary
The use of in vivo imaging and modulation tools to study neural function in the visual system have the potential
to deliver transformative scientific discoveries and advance translational science. In particular, calcium imaging
and optogenetics provide cell-type specific resolution of the neural circuits involved in visual processing and
behavior. Despite the major advances in technology, and the enthusiastic use of these tools in rodent and
smaller animal models for basic neuroscience applications, these approaches have been incorporated relatively
slowly in large-brain animal models that have neural and perceptual functions more similar to humans (e.g., non-
human primates, ferrets, and others). Further, although these methods can provide significant advantages for
translational studies, they are not commonly used in disease models for pre-clinical testing and optimization in
the eye or brain. The slow implementation of these methods in both in the eye and in large brain animal models
is largely due to the complexity of establishing the hardware and viral transfection parameters to consistently
perform these experiments. Issues relating to, eye and respiratory movements that distort light delivery and
recording, immune responses, anesthesia and limited signal to noise, particularly deep in tissue all play a role.
Yet, these are common challenges faced by the in vivo imaging community that are readily overcome with shared
expertise and new technical advances are continuously pushing back the boundaries of what is possible. This
application proposes a 2.5 day symposium that brings together world-leading scientists, engineers, and clinicians
from around the world to discuss major progress in cutting-edge neural imaging and modulation methods to
study function in the visual system in vivo. A major goal of the conference is to promote in depth discussions and
knowledge-transfer between investigators to implement ‘best practices’ for neural imaging and modulation of
activity in the visual system. Moreover, we provide a set of career development workshops aimed at increasing
diversity and representation in vision research. We have devised a strategic plan to attract scientists-in-training
(graduate students and postdocs) to the conference. In particular, we have invited a great mix of established and
junior faculty with strong record in mentoring, provided ample speaking opportunities at the conference to these
young investigators, and will award a generous number of travel awards to these young scientists to attend the
conference. Their participation will shape and implement the new path forward to making discoveries in the visual
system using these cutting-edge tools.

Public health relevance
Project Narrative The use of in vivo imaging approaches paired with genetically encoded sensors and actuators (e.g., calcium imaging, optogenetics, and others) to study visual function has led to fundamental discoveries in visual neuroscience, but also has tremendous potential to transform pre-clinical development of therapies and treatment of blinding diseases. The 33rd Symposium of the Center for Visual Science brings together a diverse array of scholars who are leaders in these state-of-the-art methods to study and manipulate visual function in the eye and brain at unprecedented resolution and scale. The meeting will provide a forum to discuss recent discoveries, and foster new collaborations between technology developers, neuroscientists and clinicians at all career stages with an emphasis on large animal models and translation.